Cellular mechanisms of astringency transduction and sensation

PROJECT SUMMARY
Astringency is a dry, puckering flavor sensation that is elicited by phenolic compounds, including tannins, in
plant-based foods. The sensation of astringency can drive food choice and potentially impact whether or not we
consume healthy, phenol-rich foods. Astringency has long been thought to be a tactile sensation, transduced by
oral mechanoreceptors that sense roughness; however, there are gaps in knowledge regarding the mechanisms
that underlie phenol transduction and astringent sensation. Multiple models of phenolic compound transduction
have been proposed. Some rely on tannin-induced alterations in the biomechanical properties of saliva and the
mucosal surface, resulting in enhanced surface roughness, which is then sensed by mechanosensory neurons
in the oral mucosa. Other models implicate chemosensory mechanisms of astringency transduction, mediated
either by oral mucosal cells that signal to other somatosensory neurons, or direct chemosensory transduction
through somatosensory neurons. At this time, there is not a conclusive answer as to whether astringent flavor is
chemosensory, mechanosensory, or a combination thereof. Our preliminary data suggest that phenolic
compounds are transduced by a trigeminal mechanosensory neuron subpopulation that is tuned to detect
movements. This activation occurs in the absence of oral movements, suggesting a chemosensory mode of
transduction. Thus, we hypothesize that phenolic compounds directly activate a movement-detecting, tongue-
innervating trigeminal mechanosensory neuron subpopulation through chemosensory mechanisms, and that this
activation is necessary for astringent perception. In this proposal, we will use a combination of transgenic
animals, pharmacology, and molecular methods to define the modes of astringency transduction (e.g.,
chemosensory or mechanosensory), identify the cellular compartments necessary for transduction and
sensation, and determine the molecular signatures of astringent-responsive, tongue-innervating sensory
neurons. We will first define the neuronal mechanisms of transduction of astringent compounds (Aim 1) using in
vivo and ex vivo functional imaging. Then, we will identify the neuronal and cellular mediators necessary for
aversion to astringent compounds using behavioral preference testing (Aim 2). Finally, we will establish the
molecular signatures and receptor profiles of tongue-innervating sensory neurons using single cell RNA
sequencing and computational analysis (Aim 3). Collectively, these studies will be among the first to
systematically test the cellular mechanisms of phenolic compound transduction and sensation, with the long-
term goal of understanding the contributions of oral somatosensory neurons to flavor construction.

Public health relevance
PROJECT NARRATIVE Astringency is a drying sensation evoked by phenolic compounds in many plant-based foods that can drive food choice. Although astringent sensation is believed to be transduced by trigeminal neurons, whether transduction occurs through chemosensory or mechanical mechanisms is not known, nor are the identities of neurons involved. This proposal seeks to determine the mechanisms of transduction of phenolic compounds and molecularly identify neurons involved in transduction, with a long-term goal of understanding the identities and functions of oral somatosensory neurons that contribute to flavor and food choice.